Fred Hutchinson Cancer Center Lung SPORE

Project Summary/Abstract – Overall
The Fred Hutch Lung SPORE consists of three innovative projects, three supportive cores, and the required
Developmental Research Program and Career Enhancement Program. We have leveraged the strengths of the
investigators and our Center to tackle three critical barriers precluding meaningful improvements in lung cancer
survival rates: lack of effective therapies for small cell lung cancer (SCLC), sub-optimal response rates of non-
small cell lung cancer (NSCLC) patients to immune checkpoint inhibitor therapy, and the lack of effective targeted
therapies for KRAS mutant lung cancers. To overcome these barriers, we propose the following three projects:
1) Targeting the Neutrophil Lineage to Enhance Immune Checkpoint Inhibitor Efficacy in NSCLC, 2) Treating
metastatic lung cancer by targeting mutated KRAS with engineered T cells, and 3) Targeting LSD1 to augment
response to PDL1 inhibition in SCLC. These projects will be supported by an Administrative Core (AC), a
Biostatistics and Data Science Core (BDSC), and a Histopathology and Biospecimen Core (HBC).

Public health relevance
Project Narrative – Overall The Fred Hutch Lung SPORE consists of three innovative translational research projects, three supportive cores, and the required Developmental Research Program and Career Enhancement Program. We have leveraged the strengths of the investigators and our Center to tackle three critical barriers precluding meaningful improvements in lung cancer survival rates: lack of effective therapies for small cell lung cancer (SCLC), sub-optimal response rates of non-small cell lung cancer (NSCLC) patients to immune checkpoint inhibitor therapy, and the lack of effective targeted therapies for KRAS mutant lung cancers.